Single cell multi-omics approaches in identifying driving cells and genes in pediatric MODS patients requiring ECMO support

PROJECT SUMMARY
My long-term goal is to develop innovative diagnostic and therapeutic methods for pediatric diseases in the
intensive care unit (ICU), using cutting-edge single-cell multi-omics techniques and machine learning
approaches. My previous research focused on identifying novel drugs, biomarkers, prognostic, and diagnostic
markers for various diseases and cancers using big data approaches. However, MODS in pediatric patients with
veno-arterial extracorporeal membrane oxygenation (ECMO) support has drawn my attention, as the survival
rate for severe MODS patients with ECMO support is very low and there are no clinical or molecular biomarkers
available to diagnose deterioration of MODS patients requiring ECMO support. To gain a deeper understanding
of the cellular and molecular mechanisms associated with MODS deterioration who may require advanced life
support, I aim to utilize advanced single-cell multi-omics and machine learning approaches. My previous
research using bulk RNA-seq analysis on a small sample size showed that dysregulation of the immune response
and epigenetic variations are significant factors associated with MODS deterioration in patients requiring ECMO
support. However, a more detailed analysis using advanced single-cell multi-omics and machine learning is
needed. The objective of this award is to use cutting-edge single-cell multi-omics techniques to investigate the
cellular heterogeneity and their dynamics, as well as their transcriptional regulatory elements in MODS and
ECMO patients at two different time points. Furthermore, a machine learning approach along with bulk RNA-seq
will be implemented to identify crucial cells and genes associated with MODS patients’ deterioration who may
require ECMO support. The successful completion of this research will expand my knowledge in single-cell multi-
omics, statistics, machine learning approaches, immune responses, and pediatric diseases. I have gathered a
team of eight renowned experts in the fields of big data science, immunology, single-cell multi-omics, pediatrics
rare diseases, statistics, rare diseases, machine learning, and immunology to act as my mentors, advisors, and
collaborators. These experts include: Primary Mentor Dr. Bin Chen in translational bioinformatics from MSU, co-
mentor Dr. Qing-Sheng Mi in immunology and single-cell multi-omics from Henry Ford Health System, co-mentor
Dr. Surender Rajasekeran in pediatrics rare diseases from Spectrum Health Hospital, co-mentor Dr. Lana
Garmier in single-cell multi-omics and immune disease from the University of Michigan, Advisor Dr. Haiyan
Huang in statistics from the University of California, Dr. Jeremy Prokop in rare diseases from MSU, Dr. Jilian
Tang in machine learning and single-cell multi-omics from MSU, and Dr. Mei-Sze Chua in immunology from
Stanford University. With the support of my mentors, advisors, and collaborators, this award will prepare me to
develop a deeper understanding of MODS research and the application of single-cell multi-omics in translational
research with a broad impact.

Public health relevance
PROJECT NARRATIVE Multiple organ dysfunction syndromes (MODS) frequently occur in pediatric patients and severe MODS patients needed Veno-Arterial extracorporeal membrane oxygenation support (ECMO) (label as ECMO patients) as a palliating maneuver to recover their cardiopulmonary function. The major knowledge gap exists regarding the cellular and molecular mechanisms underlying MODS deterioration for their advanced life support. The proposed work will provide a comprehensive overview of cellular and molecular mechanism associated with deterioration of MODS patients who may require ECMO support, which will be applicable for early diagnostic purposes.